Pittsburgh Training Grant in Pediatric Pulmonary Medicine

ABSTRACT
This first competitive renewal application seeks to continue NHLBI funding for a T32 Training
Grant at one of the premier fellowship training programs in Pediatric Pulmonary Medicine in the
United States (U.S.). The specialty focuses on respiratory diseases, the most common cause of
emergency department visits and hospitalizations among children in the U.S. Approximately
1,194 board-certified pediatric pulmonologists (or only ~4.6% of the 25,957 board certified
pediatric subspecialists in 2019) serve this large population of children. Few pediatric
pulmonologists have had research mentors or academic role models with a strong track record
of excellence in research. In spite of a well-recognized need to train more scientists and
physician-scientists in this field, there are currently only four T32 training grants in Pediatric
Pulmonary Medicine in the U.S. Over the last decade, our fellowship program has markedly
contributed to the small cadre of physician-scientists and scientists in pediatric pulmonary medicine. Such
contributions have been enhanced by NHLBI funding of our training program since 2016, as all 7 graduates
of this T32 Training Program over the past 4.5 years are in an academic track and have been
highly productive, as measured by the number of publications directly resulting from
participation in the T32 program, as well as by subsequent funding from intramural and/or
extramural sources, including career development awards from the NHLBI, the American Heart
Association, and the Cystic Fibrosis Foundation. Our interdisciplinary training program is built on
the strong research environment at the University of Pittsburgh and provides trainees with the
fundamental tools and skills to design, implement, and interpret meaningful research projects.
Faculty mentors are highly interactive, academically productive, and truly dedicated to the
training of scientists and physician-scientists. The goal of this proposal is to continue to provide
a prime source of well-trained physician-scientists and Ph.D. scientists to conduct cutting-edge
research in pediatric pulmonary diseases. To achieve this mission, we seek to provide, within a
single center, the research role models, mentorship, and rich environment necessary for
nurturing such individuals and ensuring their success.

Public health relevance
Project Narrative Pediatric Pulmonary Medicine is one of the smallest pediatric subspecialties. Very few pediatric pulmonologists have had adequate training and mentorship in research, and thus lack the skills to perform cutting-edge research in pediatric pulmonary diseases. This training grant will continue to educate a new generation of pediatric pulmonologists and Ph.D. scientists, who can play a role as leaders and researchers in pediatric pulmonary medicine.